Administrative Core

PROJECT ABSTRACT
The goal of the Center for Redox Biology and Cardiovascular Disease CoBRE is to establish a nationally
recognized advanced research and training program facilitating the development of junior faculty research to
major independent research funding in the area of redox biology and cardiovascular pathophysiology. In order
to accomplish this goal, a multifaceted plan for research program development along with mentorship and
training is required. The Administration Core A provides implementation and management all CoBRE program
initiatives including advanced research core facilities, mentorship program for junior faculty development,
External and Internal Advisory Committees along with a Senior Mentoring Committee, an annual scientific
colloquium, continuing education, and formal evaluation procedures, and the pilot grant mechanism that supports
development of promising projects from junior faculty. The Administration Core is managed by the CoBRE PI
along with coordinator assistance, and business management oversight of the program budget. This core will
centralize all CoBRE program documentation and reporting in compliance with NIGMS CoBRE requirements.